PHOTOTRANSDUCTION IN HEALTH AND DISEASE

Abstract
Phototransduction is a fundamental biological process involving a set of biochemical reactions in
photoreceptor cells initiating vision. The long-term goal of this research program is to understand the molecular
mechanisms underlying the biochemical events in phototransduction under normal and diseased states.
Rhodopsin and cone opsins are the light receptors in photoreceptors cells that initiate vision upon stimulation
by light. The primary focus here is on rhodopsin structure, function and dysfunction. Rhodopsin plays a central
role in phototransduction as the initiator of signaling and also plays an important role in maintaining the health
of photoreceptor cells. The rhodopsin gene is a hot spot for mutations causing inherited retinal diseases such
as retinitis pigmentosa (RP) and congenital stationary night blindness (CSNB), which currently have no cure or
effective treatment. Rhodopsin is a prototypical G protein-coupled receptor and therefore findings here can
provide insights on other members of this superfamily of proteins that share commonalities in structure and
mechanisms of action. Despite the wealth of knowledge available for rhodopsin, gaps in our structural and
molecular understanding of the receptor still exist and a mechanistic description on the effect of mutations in
the light receptor causing vision disorders is incomplete. Less is known about the structure, function, and
dysfunction of cone opsins, a secondary focus here in one aim. Three aspects of rhodopsin structure and
function will be examined in this proposal. Opsins must adopt a proper three-dimensional structure for proper
function in photoreceptor cells. In aim 1, the misfolding and aggregation of a set of mutants that cause RP and
a mutant in a cone opsin causing blue cone monochromacy will be characterized, and the resulting
consequences in the retina of mouse models examined. Rhodopsin forms a supramolecular structure at its site
of action in the rod outer segment of photoreceptor cells to carry out its function under scotopic conditions. In
aim 2, the dynamics of this supramolecular structure will be visualized and the impact of diseased states on
this membrane organization will be examined. The structure of rhodopsin is finely tuned to prevent activation of
the receptor in the absence of light stimulation. Constitutive activity of rhodopsin can lead to a variety of
phenotypes causing CSNB or RP. In aim 3, the molecular origin of the different phenotypes caused by
mutations causing constitutive activity in rhodopsin will be examined. The proposal combines the study of a
variety of genetically modified mice with innovative biophysical and biochemical methods to answer questions
raised in each aim. Results from our studies will lead to a more accurate mechanistic framework to understand
the function of the system under normal conditions and dysfunctions in inherited retinal diseases, which will
provide new avenues for scientific inquiry. The long-term impact in studying fundamental aspects of rhodopsin
structure and function will be the potential for targeted therapeutics and discovery of novel drug targets.

Public health relevance
Project Narrative Fundamental questions about membrane protein structure and function are still unanswered. Novel technologies and genetic tools are required to advance our mechanistic understanding about the action of these systems in both normal and diseased states. Our studies will reveal fundamental insights about the visual system and will reveal novel strategies to combat retinal disease.